Training Program in Cancer Biology

ABSTRACT
Despite major breakthroughs over the past few years in our basic understanding of the cellular and molecular
changes that lead to cancer, many key steps in carcinogenesis and changes in early cancers that promote
invasion and metastasis, still remain poorly defined. Rigorous training of future young investigators in cancer
biology will be essential in our quest for a deeper understanding of carcinogenesis and for the development of
better methods of early cancer detection, improved diagnosis, and effective new cancer treatments. The
Training Program in Cancer Biology (TPCB) is a multidisciplinary program across all cancer subtypes that
capitalizes on the unique strengths and training opportunities at CU Anschutz, including world renowned
research in functional genomics, experimental therapeutics, steroid receptor signaling, stem cells and organ
specific cancers (in particular lung, breast and blood). Our goal is to provide interdisciplinary training at the
cutting edge of cancer research to best prepare our trainees to compete in a biomedical research environment
increasingly focused on translational applications of basic research. Our training plan consists of laboratory
training, didactic activities, attendance at scientific conferences, professional development and career
mentoring, development of communication skills, and exposure to the clinical perspective. Based on feedback
from trainees and faculty, for this renewal we have added new training components, including mandatory
mentor training and training in rigor and reproducibility. The renewal also includes expanded opportunities for
training in quantitative biology and bioinformatics, and expanded clinical/translational and career development
opportunities. The co-PIs of this training program have been leaders in Cancer Biology training at the
University of Colorado Cancer Center and the Graduate School during the past 10 years. Resources from the
Cancer Center, the Graduate School, and individual departments are committed to support the training
program. The infrastructure of the Cancer Center is particularly important as it provides core resources
available to training faculty that are therefore available to the trainees. The proposed program will include pre-
doctoral training through the graduate training program in Cancer Biology, which is housed in the Graduate
School, and post-doctoral training for PhD and PhD/MD scientists. A total of 38 training faculty were selected
based on their scientific expertise and track record of mentorship. The first cycle of this T32 grant was highly
successful, with all slots competitively filled. For the second cycle of this grant, we propose to support 4
postdoc and 4 predoctoral trainees each year. We will select trainees from external and internal pools based
on their research and academic records and commitment to cancer research. We are committed to providing
comprehensive training at all levels so as to best prepare our trainees for successful careers in biomedical
science inside or outside academia.

Public health relevance
Narrative Training devoted to understanding molecular and cellular mechanisms of cancer is vital to the development of novel treatments and therapies for patients.